A mechanistic approach to understand the tissue-specific development of toxicity in response totransgenerational chronic arsenic exposures

Title: A mechanistic approach to understand the tissue-specific development of toxicity in response to
transgenerational chronic arsenic exposures
Abstract: Arsenic compounds are common environmental toxicants associated with numerous adverse health
effects in humans. Several genetic, molecular and cellular processes have been implicated in the complex
etiology of arsenic toxicity, although the precise mode of action is not fully understood. Maternal exposure to
chronic arsenic at concentrations below U.S. Environmental Protection Agency’s recommended maximum of 10
μg/L has been related to several birth and developmental defects indicating a transgenerational impact in toxicity
development. Maternal chronic exposures also lead to preferential accumulation of arsenic in certain tissues
making them more vulnerable to toxicity effects compared to the rest. However, the relationship between
transgenerational exposure, localized arsenic accumulation and subsequent toxicity impacts are unknown.
Previously, we showed exposure to chronic arsenic concentrations over 10 generations increased resilience to
high arsenic levels and decreased growth and reproduction in our model organism Daphnia, indicating the
presence of a significant maternal influence in long-term arsenic toxicity development. Additionally, we identified
gene pathways and metabolic proteins that showed differential expression in response to transgenerational
arsenic exposure in Daphnia. In this application, we build on these results to identify tissue specific sub-cellular
processes that regulate long-term phenotypic indicators in animals for a more mechanistic understanding of
arsenic toxicity. The overarching goal is to establish functional links between gene expression and associated
phenotypic manifestations in response to long-term arsenic exposure in Daphnia to identify tissue-specific
biomarkers for a more efficient assessment of individual susceptibilities. We hypothesize that transgenerational
susceptibilities to maternal exposure will be mediated by both tissue-specific (unique) as well as common
metabolic and cellular processes in Daphnia. Specifically, we aim to – (1) Detect tissue-specific uptake of
arsenic in response to transgenerational chronic exposure using techniques in laser-ablation-ICP-MS; (2)
Identify tissue-specific gene expression levels in response to transgenerational arsenic exposure using
techniques in RNA sequencing and comparative genomics; and (3) Detect conserved genetic biomarkers of
arsenic toxicity in mammalian cells using techniques in qPCR. Identifying evolutionary conserved genetic
processes regulating toxicity responses to environmentally relevant chronic concentrations will advance our
understanding on the mode of action of not only Arsenic but other common environmental toxicants, potentially
leading to effective mitigation strategies in vulnerable human populations as incidences of Arsenic continues to
rise across the world.

Public health relevance
Narrative Arsenic compounds are common environmental toxicants associated with numerous health effects in humans. We will use the keystone aquatic herbivore, Daphnia to identify tissue-specific biomarkers of arsenic across generations of environmentally relevant chronic exposures. Identifying similar conserved biomarkers in mammalian systems can advance our understanding of toxicity developments of common environmental toxicants in humans leading to effective risk mitigation strategies.